THREE-TIERED ALZHEIMERS TRAINING FOR WV PROFESSIONALS

The overall goal of this project is to enhance the detection, assessment and family care of Alzheimer's disease in the rural counties of West Virginia through a state-wide educational program. The specific aims include: 1) to provide training in assessing the cognitive status of elderly clients and the adequacy of their family caregiving arrangements by health care professionals in 28 W.V. counties; 2) to provide training for clinical preceptors (medicine, nursing and social work) at eight rural health network sites; 3) to implement a training dissemination methodology which addresses problems raised in the current grant funded project; 4) to compare the education outcomes from the two projects; 5) to evaluate the patient care outcomes from the training of the local health care professionals; 6) to facilitate networking within counties between health care professionals involved with Alzheimer's disease care; and 7) to facilitate networking state-wide between health care professionals involved with Alzheimer's disease care. The methodology includes: 1) training of staff development personnel from home health, mental health, senior service, and adult protective service agencies; 2) training county professionals in 28 counties at 14 local workshops using the staff development trainees as trainers; 3) train clinical preceptors (medicine, nursing, social work) at eight Rural Health Initiative Networks sites; 3) evaluate educational outcomes at all training sites; 4) evaluate patient care outcomes from the training of local health care professionals; 6) create and disseminate 28 county resource directories for older adults; 7) create and disseminate a state- wide data base of services for older adults with dementing illnesses.